GONADOTROPHIN RELEASING HORMONE ANTAGONIST/TREATMENT ISOSEXUAL PRECOCITY

The purpose of this study is to investigate the efficacy of a potent gonadotrophin releasing hormone antagonist "LRH-77" in the treatment of central isosexual precocity in a limited number of patients by comparing LH and FSH release prior to, during and following therapy.